Thalamocortical interactions

The proposed research will test related hypotheses that thalamus plays a heretofore neglected and
critical role in cortical processing. In particular, many thalamic nuclei, that together comprise the
majority of thalamic volume and that were previously mysterious in function, we now suggest are
critically involved in information flow and functional, dynamic binding between cortical areas via
cortico-thalamo-cortical pathways. We propose to study these pathways using the mouse
somatosensory system as the model involving both in vitro slice preparations and an in vivo
behaving preparation. It appears that, in many and perhaps all cases, cortical areas are connected
by both direct and these transthalamic pathways. The transthalamic pathways are only recently
appreciated, and we aim to explore some basic roles such pathways play in cortical processing. To
begin understanding the role of such pathways, we propose to probe basic circuit properties of
these pathways to better understand the role of the transthalamic pathways in higher cognitive
functioning.

Public health relevance
PROJECT NARRATIVE We must better understand thalamocortical relationships and the role of thalamus, using the somatosensory system as the model, to follow information flow and other aspects of functioning between cortical areas. This fundamental information may be a prerequisite to understanding and better dealing with a number of cognitive defects, like schizophrenia, Alzheimer’s, etc.